Quantitative Multimodal Imaging Biomarkers for Combined Locoregional and Immunotherapy of Liver Cancer

Project Summary
Liver cancer is the fourth most common cause of cancer-related death worldwide. Hepatocellular carcinoma
(HCC) is the most common type of primary liver cancer and is on the rise in the western world. Minimally inva-
sive, catheter-based locoregional therapies (LRT), such as transarterial chemoembolization (TACE), are now the
mainstay treatments for intermediate to advanced stage HCC and are included in all management guidelines.
TACE is a palliative therapy that prolongs survival by controlling intra-hepatic tumor progression via targeted is-
chemic injury, paired with the delivery of highly concentrated chemotherapy into the tumor-feeding artery. More
recently, systemic immunotherapies (IMT), speciﬁcally immune checkpoint inhibitors, have emerged as an im-
portant treatment option for HCC to boost the body's own immune response against the tumor. While IMT is
promising for many cancers, only 15-30% of HCC patients respond to this type of therapy. TACE is increasingly
used in conjunction with IMT, both in neoadjuvant and adjuvant scenarios. Recent efforts show that TACE can
dramatically alter the tumor microenvironment (TME) to become more immune-permissive, enabling more ef-
fective immune cell recruitment against the tumor through IMT. Thus, the LRT+IMT combination is a likely path
forward for HCC treatment strategies. In this context, there is an urgent and unmet clinical need for robust, non-
invasive quantitative biomarkers to help guide therapeutic decision making and assess therapeutic outcome early
during treatment. Previously, our team developed clinical and preclinical advanced imaging, image analysis, and
imaging biomarkers to study, guide and assess HCC treatment with TACE alone using multiparameter magnetic
resonance imaging (mpMRI) and magnetic resonance spectroscopic imaging (MRSI). We developed random
forests and convolutional neural networks for liver segmentation, tissue classiﬁcation and nonrigid registration to
map these results into the clinical treatment environment. Using graph convolutional neural networks, we pre-
dicted and assessed therapeutic outcomes. In a rabbit model of liver cancer (VX2), using Biosensor Imaging of
Redundant Deviation in Shifts (BIRDS), we successfully characterized the metabolic state of the TME with respect
to extracellular acidosis, before and after TACE. We now propose to develop robust quantitative biomarkers for
combined LRT+IMT assessment and outcome prediction in humans. We will develop novel image analysis (Joint
Domain Learning with Structure-Consistent Embedding by Disentanglement) and characterize the changing TME
over the course of LRT+IMT by deriving information from longitudinal mpMRI (with liver-speciﬁc contrast) and/or
multiphase computed tomography (mpCT), learning across modalities via domain adaptation. Since LRT+IMT is
expected to reduce extracellular acidosis in treated liver tumors, we propose to develop high-resolution advanced
BIRDS in the rabbit VX2 model with novel machine learning to spatially characterize changes in extracellular
acidosis due to LRT+IMT, enabling focus on the peritumoral region where immune activation is most enhanced.
These developments will ultimately facilitate personalized HCC treatment stratiﬁcation.

Public health relevance
Project Narrative This grant is aimed at enhancing our ability to study and assess liver cancer treatment using locoregional therapy in combination with systemic immune therapy. At the core of this effort is the unmet need for advanced imag- ing which can track the combined locoregional and immune therapies, and to that end we will develop, evaluate and translate advanced imaging, machine learning and image analysis methods to predict and assess clinical outcome with non-invasive imaging biomarkers based on characterization of liver tumor microenvironment. The resulting predictions and assessments will lead to improved patient care through more informed treatment strati- ﬁcation and clinical decision making.